IRACDA at OHSU

Project Summary/Abstract
A diverse U.S. biomedical research workforce is necessary for improving health through innovative basic,
clinical, and translational research. Despite decades of efforts to increase representation of underrepresented
racial and ethnic groups in science, representation remains unacceptably low in academia. IRACDA at OHSU
is a proposed mentored postdoctoral career development training program that will partner with Pacific
University to provide teaching training and opportunities for a diverse group of IRACDA scholars from
experienced and invested teaching mentors. The main objective of IRACDA at OHSU is to recruit and train a
diverse pool of postdoctoral scholars in safe and inclusive environments that will ensure their successful
transition to independent academic research and teaching careers. Scholars will be trained in conducting
rigorous and reproducible research, as well as scientific teaching principles and evidence-based pedagogy
practices. A cohort of 3 scholars will be appointed each year, which will provide a good balance between
creating a community of fellows and the program's ability to provide personalized training and mentoring.
Scholars will be selected based on academic achievement and potential, as well as on the strength of the
potential mentor-mentee match. To facilitate a positive experience, all OHSU IRACDA research mentors are
required to complete training in the OHSU Mentoring Academy. Moreover, during scholar onboarding, mentors
will work closely with scholars to generate a detailed Individual Development Plan (IDP) that will incorporate a
research plan with focus on rigor and reproducibility, as well as a personalized career development plan. The
teaching mentors at Pacific University have a record of excellence in evidence-based approaches to teaching
in a STEM field. The IRACDA at OHSU training plan has concurrent paths in each year of the fellowship for
mentored research, career development, and teaching training. Year 1 is focused on setting the scholars up for
success during their training, with foundational programming such as the IDP, formal training in responsible
training of research, monthly program seminars, and training in teaching pedagogy and tools. Year 2 centers
training as an iterative process involving practice and feedback for presenting research, grant writing,
mentoring, and teaching. Activities in year 3 are designed to provide the scholars with opportunities to reflect
on their practices, embrace growth opportunities, and prepare for the transition to independent positions by
applying for independent funding. Scholars will explore networking opportunities at OHSU, Pacific University,
and at National/International Scientific Conferences at least once per year, and receive manuscript and grant
writing training, as well as assistance preparing application materials for faculty positions. IRACDA at OHSU
will benefit both post-doctoral fellows, as well as the partner institution, by providing new and improved science
curriculum, authentic research experiences and critical mentoring for underrepresented students to enhance
academic advancement and train the next generation of scientists.

Public health relevance
Project Narrative IRACDA at OHSU is a program that aims to train and support a diverse generation of future faculty, in partnership with Pacific University. IRACDA scholars will receive mentorship in conducting exceptional scientific research at OHSU, training and practice in evidence-based teaching methods at Pacific University, blended together by personalized career development and guidance from dedicated program staff at both institutions. As they grow through the program, IRACDA scholars will not only impact the future of science and education, but also will transform our existing programs and institutions.